Contingency Management for Veteran Smokers With or at Risk for Cancer

The goal of this Proof of Concept and Clinical Trial project is to evaluate the acceptability, feasibility, and
efficacy of Contingency Management (CM) for smoking cessation among Veterans in lung cancer screening
(LCS) or cancer care in Veterans Affairs (VA) clinics. Smoking at the time of LCS or cancer diagnosis is
associated with treatment failure, shortened lifespan, and diminished quality of life. Beyond the increased
morbidity and mortality, smoking after a cancer diagnosis is associated with an estimated $3.4 billion in
healthcare costs. Despite these risks, the VA does not routinely integrate smoking cessation treatment into
LCS screening or cancer care, and quit rates are low. CM is a behavioral treatment that promotes cessation
through positive reinforcement through delivery of incentives (rewards) when abstinence is biologically verified.
Newer CM technologies allow for remote (mobile) biological verification of smoking abstinence, increasing
scalability of CM for smoking cessation among outpatients. Research indicates that CM must be tailored to the
clinical population and context. This staged investigation will occur in three phases. In Year 1 (Focus Groups),
we will iteratively develop an acceptable mobile CM protocol using qualitative feedback from Veterans in VA
patients in LCS or in cancer care (n=15) and LCS and oncology staff (n=10) (Aim 1).
In Year 2 (Pilot Study), we will examine the feasibility of mobile smoking cessation CM with for VA patients in
LCS or in cancer care (Aim 2). In a single arm study (n=20), Veterans in VA LCS or cancer care will receive
mobile CM plus behavioral counseling and cessation medication over 5 weeks. Measures will be completed at
Week 0 (Baseline) and 5 (Study End). We will use the following Go/No Go criteria as endpoints to measure
success: 1) completion of core staff hiring and training; 2) adaptation of CM protocols for VA patients in LCS or
cancer care and refinement of fidelity measures/procedures; 3) feasibility, as evidenced by ability to recruit
≥70% of the target sample within the 12 month timeline; 4) engagement, as measured by ≥50% of participants
attending ≥25% CM sessions and ≥25% video uploads during the CM phase (Weeks 2-5); 5) completion of
study measures at Study End (Week 5) in ≥60% of enrolled participants; 6) data quality checks for enrolled
participants. If the pilot study is successful by the above criteria, we will conduct a Randomized Controlled Trial
(RCT) (Yrs 3-6) to assess efficacy of mobile CM compared with treatment as usual (TAU) (Aim 3). Veterans
diagnosed with cancer or in LCS will be randomized to receive a 5-week CM condition (CM plus behavioral
counseling) or TAU (referral to VA Tobacco Cessation Clinic and VA quitline). Both groups will receive
pharmacotherapy. Endpoints will be measured at Weeks 5, 12, and 24. Hypothesis 1 is that compared to TAU,
the CM condition will show improvements in treatment engagement (motivation to quit (Contemplation Ladder);
adherence with TUD medication (Timeline Followback, TLFB)). Hypothesis 2 is that compared to TAU, the CM
condition will show improvements in smoking cessation outcomes (cigarettes per day (TLFB); quit attempts;
and nicotine dependence severity (Fagerström Test of Nicotine Dependence, FTND)). As an Exploratory Aim,
we will assess seven-day point prevalence cigarette abstinence, assessed through self-report and exhaled
carbon monoxide (CO) and/ or salivary cotinine levels, as clinically indicated. This groundbreaking
investigation leverages novel CM approaches to improve smoking cessation outcomes in high-risk patients
with or at risk for cancer.

Public health relevance
This project examines the acceptability, feasibility, and efficacy of a tailored mobile Contingency Management (CM) smoking cessation intervention among Veterans in VA lung cancer screening (LCS) and cancer care. Smoking at the time of LCS or cancer diagnosis is associated with poor prognosis, yet quit rates are low. CM uses positive reinforcement by providing monetary incentives with bioverified abstinence. Current smoking cessation CM methodologies have never been tested among Veterans with cancer or in LCS care. We will conduct focus groups with 15 current or former smoker VA patients and 10 VA staff from oncology and LCS clinics to ensure acceptability of CM. We will then conduct a single arm pilot study in which 20 Veterans in LCS or VA cancer care receive smoking cessation CM plus behavioral counseling and pharmacotherapy. If successful, we will conduct a randomized controlled trial comparing CM plus behavioral counseling (n=60) to usual care (n=60) in improving treatment engagement and smoking cessation outcomes.